Menopause-related Vasomotor Symptoms and Cardiovascular Health

PROJECT SUMMARY/ABSTRACT
The menopause transition is marked by a sharp rise in cardiovascular disease (CVD) events in women, but the
mechanisms through which menopause contributes to CVD risk in midlife women are not known. Hot flashes
are a hallmark feature of the menopause transition and are experienced by nearly 80% of menopausal women.
Although hot flashes have been widely regarded as bothersome yet benign symptoms, emerging data have
linked hot flashes to CVD risk. Inflammation and vascular dysfunction are potential drivers that may explain the
relationship between hot flashes and CVD. We hypothesize that among peri- and post-menopausal women
with elevated cardiometabolic risk, vasomotor instability triggers systemic inflammation that in turn promotes
downstream vascular dysfunction, which contribute to heightened CVD risk. Neurokinin-3 receptor (NK3R)
antagonists are a novel therapy that were recently approved for the treatment of moderate to severe
menopause-related hot flashes. Because NK3R antagonists centrally suppress hot flashes, they offer a unique
opportunity to test whether treating hot flashes in isolation improves CVD risk. We propose to prospectively
study 120 peri- and post-menopausal women with cardiometabolic risk factors across a range of hot flash
burden (low, moderate, high). To gain further mechanistic insights into the hot flash-CVD link, we will pursue
two related lines of investigation. In Aim 1, we will study the effect of hot flash burden on peripheral endothelial
and coronary vascular function as measured by brachial artery ultrasound flow mediated dilation (endothelial
function) and cardiac perfusion PET (coronary microvascular function) among 120 peri- and post-menopausal
women. In Aim 2, we will conduct a randomized placebo-controlled trial to assess the effect of hot flash
suppression via NK3R antagonist on endothelial function and molecular pathways of inflammation (select
eicosanoid metabolites and inflammatory biomarkers) among 80 peri- and post-menopausal women with
moderate to high burden of hot flashes. This proposal leverages a unique and highly experienced
multidisciplinary team of investigators with expertise in women’s CVD, menopause physiology, vascular
biology, advanced cardiovascular imaging, clinical trials, and bioinformatics. These studies have the potential
to be paradigm shifting and may recast hot flashes as an important driver of CVD in menopausal women and
not just a bothersome symptom. If suppressing hot flashes improves vascular health and/or attenuates select
inflammatory pathways, our findings will advance mechanistic insights into how menopause accelerates CVD
risk in women and support broader efforts to identify women with moderate or severe hot flashes and abrogate
symptoms as a means of optimizing CV health through the menopause transition.

Public health relevance
PROJECT NARRATIVE (PUBLIC HEALTH RELEVANCE) Menopausal hot flashes have been linked to heart disease risk in women. This research will examine the relationship between the burden of hot flashes with coronary and peripheral microvascular function and will assess whether suppressing hot flashes improves vascular function and inflammation. Our work has the potential to shift the understanding of the health implications of hot flashes and may inform strategies to prevent heart disease related to menopause.